A fortified lipid bilayer platform for improved drug packaging and therapeutic delivery

Liposome, composed of a lipid bilayer comprising phospholipids (PL) and sterols such as cholesterol (Chol), has
been extensively used for packaging and delivery of therapeutic agents due to its intrinsic biocompatibility and
biodegradability. While most approved liposomal nanotherapeutics can improve pharmacokinetics (PK) and
reduce systemic toxicities, improvements in therapeutic efficacy and overall survival are disappointing,
underscoring the urgent need for enhanced therapeutic delivery. Chol plays a critical role in fortifying membrane
packing and reducing bilayer fluidity and permeability by promoting the liquid condensed state in lipid
membranes, enhancing bilayer rigidity and strength. Lipid bilayers with high levels of Chol are generally more
stable than those without or with less Chol. However, under the physiological environment, Chol is rapidly
extracted from the bilayer by biomembranes and serum proteins, which jeopardizes bilayer stability and results
in premature content leakage, fast blood clearance and unwanted adverse effects, leading to suboptimal clinic
efficacy. In addition, although enhanced permeability and retention effect allows nanotherapeutic accumulation
to the periphery of diseased tissues, intracellular internalization and tissue penetration remain inefficient due to
the tenacious resistance imposed by high interstitial fluid pressure and dense extracellular matrix, compromising
the therapeutic outcome. These phenomena present formidable barriers for lipid bilayer-based therapeutic
delivery. To tackle these key challenges, the overall vision of my research program is to establish a stabilized
lipid bilayer with improved physicochemical properties that can further improve drug delivery and selectively
fortify intracellular uptake and infiltration at target sites. We have established a Chol-derived PL via covalently
attaching Chol to a PL with varied stimuli-responsive linkages. Via systemic structure activity relationship studies,
we demonstrated that Chol-derived PL blocked Chol transfer, prevented payload leakage, prolonged circulation
time, and augmented efficacy in treating lung inflammation, Alzheimer’s disease, lymphoma, pancreatic and
triple negative breast cancer models, which were linker chemistry dependent. For the next five years, the goals
of this proposal are to 1) unravel the underlying mechanisms and principles on how the structural alterations of
a sterol-modified PL bilayer that forms liposome but cannot shuttle between biomembranes will affect drug and
gene delivery via substituting Chol with other membrane sterols; and 2) establish a universal ultra pH-sensitive
charge-reversal delivery platform to boost the cellular uptake and tissue penetration efficiency via incorporating
an intelligent build-in cationization mechanism that selectively triggers effective adsorption-mediated endocytosis
and transcytosis at diseased tissues. Completing these studies will provide fundamental and functional
correlations of bilayer properties with therapeutic delivery, enable us to establish a set of design rules governing
the optimal interactions between lipid bilayer and encased drugs, and provide a paradigm-shifting toolbox to
advance the drug delivery technologies, facilitating clinical translation of treating human diseases.

Public health relevance
Project Narrative A stabilized lipid bilayer will improve the drug packaging and therapeutic delivery to the target sites compared to the conventional liposomal nanotherapeutics; and the selective cationization-induced endocytosis and transcytosis will further reinforce the intracellular uptake and tissue penetration to maximize the therapeutic potential, paving the way for the future translational applications of treating diverse human diseases.